Design and Development of an Evidence-based Cognitive Aid for Out-of-Hospital Treatment of Pediatric Patients

Prehospital pediatric care is a low-frequency, high-stake event. Medication errors and delayed interventions are
common in this domain, which could lead to severe consequences. The occurrence of many safety events can
be attributed to the relative lack of prehospital provider experience and knowledge in the care of acutely ill and
injured children in the out-of-hospital setting. Despite some efforts, there is still a lack of effective cognitive
support for prehospital providers to promote recognition of clinical conditions, reinforce protocol adherence, and
support a shared mental model in the care of children by EMS. In this project, our goal is to design and develop
a novel evidence-based, context-sensitive cognitive aid for prehospital providers to support their treatment of
pediatric patients in the out-of-hospital setting while considering three prominent research gaps: First, prior work
primarily relied on simulation to assess medical errors in prehospital children care. Even though simulation is a
promising approach for identifying medical errors and areas for improvement, the assessed medical scenarios
and identified medical errors are often limited. Second, limited research has focused on developing digital
cognitive aids for prehospital pediatric care that can account for and alert various prehospital pediatric patient
safety events. Third, the challenges of implementing cognitive support interventions in the dynamic, fast-paced,
and cognitively consuming prehospital context still persist and remain unaddressed, such as misalignment
between system design and clinical workflow, and cognitive overload of using the system under time pressure.
Considering these research gaps, we propose three compelling specific aims: 1) Characterize medical errors in
prehospital care of children through a “human-in-the-loop computational approach. 2) Design and develop
cognitive aids for prehospital providers. 3) Implement and evaluate the proposed technology solution in simulated
environments. To carry out these research activities, we formed an interdisciplinary team consisting of experts
from pediatric emergency care, human-computer interaction, natural language processing (NLP), and artificial
intelligence (AI). Our work will contribute novel knowledge, including a comprehensive assessment and
categorization of medical errors occurred during prehospital children care through a large-scale EMS EHR data
analysis, approaches to generate decision recommendations, and design insights regarding how to present
cognitive supports and suggestions to fast-paced medical teams in an easy-to-absorb, less distractive manner
to avoid alert fatigue and disruptions to workflow. This proposal aligns with the priorities of NIH in developing
novel digital health technologies to improve healthcare services delivery at the point of care.

Public health relevance
Safety events are prevalent in prehospital pediatric care, potentially resulting in childhood morbidity and mortality. Enhancing emergency care for pediatric patients in the out-of-hospital setting is of paramount importance and holds great societal benefits, as it has the potential to significantly improve patient outcomes and reduce healthcare costs. The objective of this research is to design, develop, and evaluate an evidence- based, context-sensitive cognitive aid to assist prehospital providers in recognizing patients' requirements and delivering timely interventions for the treatment and stabilization of pediatric patients in the field.